This service is for Blueprint Neurotherapeutics Network for Small Molecule (BPN-Small Molecule) and NIH Blueprint Neurotherapeutics program (BPN) requires subject matter expert support services; POP:

Subject Matter Expert (SME) for Drug Metabolism Pharmacokinetics (DMPK) to support the Blueprint Neurotherapeutics Network for Small Molecule (BPN-Small Molecule) and NIH Blueprint Neurotherapeutics program (BPN)
The NIH Blueprint for Neuroscience Research, is a collaborative framework that includes the NIH Office of the Director and 12 NIH Institutes and Centers that support research on the nervous system, established the Blueprint Neurotherapeutics Network (BPN) as a pipeline between the typical endpoint of NIH-funded research and the beginning of industry drug development. The BPN provides neuroscience researchers with funding and access to a full range of industry-style drug development services and expertise. The program is intended for projects requiring medicinal chemistry optimization and Contract Research Organization (CRO) support through Phase I clinical testing. Each project is directed by a Lead Development Team (LDT) composed of the Principal Investigator (PI), industry subject matter experts hired by NIH, and NIH staff. This team maps out a research strategy, including milestones, and oversees implementation by CROs. Bioactivity and efficacy studies are funded through an award to the PI; other research services can be provided without cost to the PI through NIH contracts.
“This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.”